RNA modification and the regulation of partial EMT in head and neck cancer

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC) is the sixth leading cause of cancer-related mortality, with
the majority of deaths attributable to tumor metastasis and failures in treatment. Because most cases of HNSCC
result from tobacco and alcohol exposure, these tumors are highly heterogeneous, greatly complicating
diagnosis, treatment, and investigations into the biology of this disease. We recently performed single cell RNA-
sequencing (scRNA-seq) in HNSCC and identified a partial epithelial-to-mesenchymal (p-EMT) transcriptional
program that is predictive of poor clinical outcomes including nodal metastasis and diminished survival (Puram
et al., Cell). Understanding the regulatory factors that control the p-EMT program in HNSCC is of critical
importance as targeting multiple genes in a complex pathway such as p-EMT is particularly challenging, yet has
the potential to significantly improve HNSCC outcomes and treatment decision-making. RNA modification
proteins, which can directly read/write nucleotide marks on RNA, have emerged as one exciting class of such
regulatory proteins. Because these proteins modulate multiple RNA transcripts, targeting RNA modification
proteins may disrupt expression of multiple disease-related genes and make resistance less likely to emerge. In
HNSCC, we have found that METTL3, an RNA methyltransferase which catalyzes the N6-methyladenosine
(m6A) modification, is a key regulator of the p-EMT program in HNSCC. In preliminary studies, we have
discovered that perturbation of METTL3 in HNSCC disrupts p-EMT signaling and reduces invasion in vitro.
However, the precise mechanisms by which METTL3 and other RNA modification proteins exert their function
are poorly understood, but may depend on changes in transcript stability and/or translation. Thus, a better
understanding of how METTL3 modulates p-EMT in HNSCC is likely to improve rational drug design and
future small molecule- and biologically-based screens in search of effective epitranscriptomic
therapeutics. We hypothesize that METTL3 antagonizes p-EMT in HNSCC by disrupting the translation of
critical p-EMT target genes. To test which domains in METTL3 are essential for its function, we will first perform
sophisticated structure-function analyses in HNSCC cell lines and patient-derived xenograft organoid (PDXOs)
(Aim 1). We will determine which domains are required for m6A function using state-of-the-art mass spectrometry
methods, while also mapping the binding partners of the critical domains. To determine if METTL3 controls the
transcription or translation (or both) of p-EMT genes, we will utilize advanced biochemical techniques including
meRIP-seq to study the stability of p-EMT RNA transcripts and polysome profiling and PAR-CLIP to investigate
the effects of METTL3 on translation of p-EMT genes (Aim 2). These studies will provide indispensable insight
into the mechanism by which METTL3 directs HNSCC tumorigenesis, specifically focusing on its regulation of
p-EMT signaling, and thereby revealing METTL3 domains that could be targeted by new therapeutics to more
effectively and specifically treat HNSCC.

Public health relevance
PROJECT NARRATIVE Although progress has been made in head and neck squamous cell carcinoma (HNSCC), the mainstays of treatment continue to be surgery, radiation, and chemotherapy, with spread to lymph nodes and poor responses to treatment representing two of the most common reasons patients die from this disease. This research proposal will investigate how METTL3 – a protein which makes small marks or modifications on RNA – may control a program called partial epithelial-to-mesenchymal transition (p-EMT), which plays an important role in tumor invasion, metastasis, and poor outcomes in patients. Our overarching goal is to identify how this RNA modification protein specifically regulates its target genes and which domains of this protein are critical for its function, thereby revealing opportunities for new, highly targeted treatments for HNSCC that may be more effective.